Medical Scientist Training Program

PROJECT SUMMARY The University of Iowa Medical Scientist Training Program (MSTP) has successfully prepared students for careers as physician-scientists since its inception as an NIH-funded MSTP in 1977. The goal of the MSTP is to recruit, nurture, and graduate a well-rounded pool of well-trained physician-scientists with the technical, operational, and professional skills necessary to transition into successful careers in the biomedical research workforce. This goal is achieved through an integrated curriculum that assimilates scientific and clinical training, constantly emphasizing the intersections between science and medicine. Students complete 1.5 years of pre-clinical medical coursework, 4 to 5 years of graduate training, and approximately 1.5 years of clinical clerkships to fulfill the requirements for both the MD and PhD degrees. We have defined seven specific objectives for our graduating students, which are measured in our evidenced-based evaluation process. Upon completion of the MSTP, graduating students will be able to: 1) Combine the knowledge bases of science and medicine to establish a strong foundation; 2) Integrate critical thinking, reasoning and rigor in the conduct of research; 3) Demonstrate integrity in research and clinical practice; 4) Demonstrate skills in oral and written communication; 5) Acknowledge the value of a welcoming, fair, and inclusive environment.; Work effectively in a professional environment that includes people from various backgrounds, demonstrating respect for individual differences; 6) Demonstrate leadership in research and clinical care; and 7) Understand the wide range of career options available for physician scientists.. The U of Iowa MSTP is led by Co-PIs Steven Lentz, MD, PhD (Director) and Pamela Geyer, PhD (Co-Director) who share a long-standing passion for mentoring and training physician-scientists. The Program incorporates specific coursework and activities throughout the course of study to provide integration and enrichment of the curriculum and foster program identity, professionalism, teamwork, communication, career development skills, and mentorship of students during transitions. The Program has 87 talented and varied faculty members who provide exciting research training opportunities. Students are extensively involved in MSTP leadership, serving as members on the Executive, Admissions, MSTP Mondays, Seminar, Retreat, and Wellness committees. The Program enjoys strong institutional support from the Deans of the Carver College of Medicine and the Graduate College, who promote the MSTP as a driver for innovation in research, education and service at the university. The majority of our graduates have gone on to careers at major academic medical centers or research institutions. This application requests support for 18 trainees per year, reflecting the strength and outcomes of our training program.

Public health relevance
PROJECT NARRATIVE The University of Iowa MSTP is committed to the goal of training outstanding students for careers as successful physician-scientists. We aspire to train individuals who will be leaders among the next generation of physician-scientists.